Digital Device ID Targeting for Increasing Medications for Opioid Use Disorder: A Feasibility and Acceptability Study

Abstract
There is a critical need to improve identification and sustained treatment of patients with opioid use
disorder (OUD) to prevent drug overdose, comorbid substance use, impaired driving, and HIV/AIDS. This
application seeks to study a novel way to solve that problem by adopting and applying a cutting-edge approach
being used to increase consumer identification and engagement by top technology and marketing companies.
This approach, called device ID targeting, has recently been replacing other digital communication outreach
methods largely for privacy reasons-- to conform to stringent European Union privacy laws-- as it involves de-
identified data.
Device ID targeting is already being applied in health (but not yet OUD) settings. During the COVID-19
pandemic, our team and others (including the CDC) have already studied and found initial success applying
these methods for targeted digital recruitment and outreach to those at high-risk for COVID-19. As a result of
the COVID-19 pandemic and its effect on use of digital/remote tools, these approaches will soon be applied to
OUD to assist in methods for identification, surveillance, and intervention among individuals with OUD.
Importantly, device ID targeting allows access to large-scale neighborhood and mobility (GPS pings) data,
which may add rich and granular data to improve OUD surveillance and interventions. This application seeks to
study the feasibility and acceptability of using device ID targeting to increase identification and retention among
participants with OUD who are not taking medications for opioid use disorder (MOUD), including studying
participants' ethical questions with this approach. Specifically, we seek to 1) develop the infrastructure needed
for a big data mapping tool that visualizes the relationship between longitudinal MOUD engagement and
mobility data collected from device ID targeting, 2) explore the feasibility of using device ID targeting to identify
and retain OUD patients, not on MOUD, and 3) explore the acceptability of using device ID targeting to identify
and retain OUD patients, not in care.
This study will collect pilot survey data with common data elements with the HEALing Communities and
other HEAL Initiative studies, in order to converge with the outcome measures from the HEAL initiative and
provide highly granular geographic/GPS movement data that can drive insights to improve delivery of MOUD
interventions. The feasibility, acceptability, and novel digital data collected, will provide our team and other
researchers with important data on whether and how to use device ID outreach approaches to improve the
timing, location, and tailoring of digital OUD outreach interventions. This research will be the first to explore this
novel and potentially highly impactful approach.

Public health relevance
Narrative There is a critical need to increase identification of individuals with opioid use disorder (OUD) to delivery interventions. Due to the current COVID-19 pandemic, researchers and policymakers have been able to develop new and impactful partnerships with industry, including digital outreach companies, to attempt to control the growing COVID-19 pandemic. These approaches will likely also be applied to address the most important problems within the field of OUD research and care, such as increasing initiation and sustainment of medications for OUD among patients with OUD, making it important to study how to apply them to address these needs.